Gut Microbiota Dysbiosis in Major Depressive Disorder is Associated with Altered Production of Aryl Hydrocarbon Receptor Ligands and Altered Microglia Function

PROJECT SUMMARY/ABSTRACT
Major Depressive Disorder (MDD) is a common disorder whose etiology remains unclear and likely
multifactorial. Serotonin reuptake inhibitors (SSRIs), fail to fully reduce the burden of disease, highlighting need
for additional studies into the pathogenesis of MDD. Alterations in gut microbiota composition (termed
“dysbiosis”) leading to altered signaling along the route of communication between the gut and the brain
(termed the gut -microbiota- brain axis) represents a novel modifiable target associated with MDD. While
several studies have linked dysbiosis to MDD, our understanding of how these changes contribute to altered
signaling along this gut-microbiota-brain axis and depressive symptoms remains limited.
This proposal aims to determine how changes in the activity of an understudied pathway of tryptophan
metabolism (the indole pathway) by the gut microbiota contributes to the pathophysiology of MDD. Using stool
and blood samples from a well characterized cohort of unmedicated MDD subjects along with healthy controls
and samples from these same unmedicated subjects after 8 weeks of antidepressant treatment, the candidate
will address two aims. First, using a shotgun metagenomics approach, changes in the capacity of the gut
microbiota to produce metabolites of the indole pathway associated with MDD will be assessed. This will be
related to changes in serum levels of indoles, activation of the aryl hydrocarbon receptor, and the ability to
modulate the activity of microglia. Next, these parameters will be assessed after antidepressant treatment to
identify changes associated with successful treatment. This study is novel given its use of unmedicated, well
characterized MDD subjects and our assessment of gut microbiome community structure/function within the
same individual after treatment (which has never been done previously). The candidate will leverage a number
of approaches including 1) metagenomics 2) metabolomics 3) in vitro assays and 4) bacterial genetics to
interrogate mechanisms of gut-brain axis signaling involved in the pathophysiology of MDD.
This proposal presents a five-year research career development program designed to provide a foundation for
future research endeavors as an independent physician -investigator researcher. The candidate is currently a
Child and Adolescent Psychiatry Fellow (in a three-year research fellowship) at UCSF. This proposal builds on
the candidate's previous experience studying host-pathogen interactions and the role of Lactobacillus species
in health and disease. This proposal will integrate new domains of expertise by his mentors, including the study
of the role of dysbiosis of complex microbial communities in the etiology of disease, neurodevelopment and the
neurobiological basis of depression, and design/implementation of clinical studies by his mentors, Dr.
Wolkowitz, Dr. Mellon, and Dr. Lynch. These skills fill critical gaps in the candidate's knowledge and the plan
outlined here will provide the candidate with a unique set of skills enabling him to transition to an independent
research career focused on gut-microbiota-brain axis signaling in neuropsychiatric disease.

Public health relevance
PROJECT NARRATIVE Major Depressive Disorder (MDD) is a common mental disorder which is poorly understood and inadequately treated. Research investigating alternative pathways involved in the etiology and pathogenesis of MDD are important to identify novel therapies to reduce the burden of this disease. In this study, we identify mechanisms by which changes in the gut microbiome contribute to changes in the production of microbial metabolites and alter signaling to the brain in the hopes of identifying novel therapeutic targets.